The role of Tex15 in shaping stochastic olfactory receptor gene choice.

PROJECT SUMMARY/ABSTRACT
The incredible specificity with which we can discern a vast diversity of smells emerges from how olfactory
sensory neurons (OSN) express olfactory receptor (OR) genes. These OR genes encode the proteins that bind
chemical odorants. Each OSN stochastically transcribes only one allele of an OR gene. An OSN can choose to
express any one of the approximately 1400 OR genes or 2800 alleles. There is no one to one relationship
between an odorant and an OR as a combination of ORs are involved in the detection of one odorant. Thus,
the diversity of ORs expressed is important to the main olfactory epithelium’s (MOE) ability to detect a vast
range of smells.
The choice of an OR gene occurs as OSN progenitors mature into an OSN. Recent work has revealed
remarkable remodeling of the local chromatin and co-expression of multiple OR genes during this period, but
the molecular mechanisms governing these processes and their connection to a singular OR allele expression
in a mature OSN remain unknown.
We show that testis expressed 15 (Tex15), a protein that has only been studied in the testes where it regulates
methylation and silencing of transposons, is crucial for stochastic OR gene choice. We find that when Tex15 is
knocked out there is a dramatic reduction in the diversity of expressed OR genes with a few OR genes
dominating stochastic choice. Strikingly, Tex15 is only transiently expressed in OSN progenitors during a
period of OR co-expression. Our central hypothesis is that Tex15 is epigenetically controlling stochastic OR
gene choice, either by regulating DNA methylation or other aspects of OR gene chromatin structure. Aim 1 will
determine whether Tex15 is required for transient co-expression of multiple OR genes in OSN
progenitors. In aim 2, we will determine whether Tex15 protein binds to OR genes. Finally in aim 3, our
experiments on primary OSNs from Tex15 null mice will determine how gene repression is mediated in
OSN progenitors – through methylation or deposition of repressive heterochromatin.
Together, these experiments will elucidate a novel aspect of how OSNs come to stochastically choose a single
OR and how Tex15 gene and protein guides this specific yet diverse choice. We anticipate this project will
uncover new and/or unexpected role for Tex15 in the MOE. This will also reveal the key molecular
underpinnings for how our sense of smell develops and may provide important insight to further understand the
mechanisms of smell disorder. The proposed fellowship will train this applicant in several innovative techniques
in biochemical, cellular, molecular, and computational neuroscience. The established faculty-student
mentorships will ensure proper scientific and professional training necessary to become a successful,
independent sensory and computational neurobiologist.

Public health relevance
PROJECT NARRATIVE The gene regulation processes by which an olfactory sensory neuronal progenitor goes from co-expressing multiple olfactory receptor genes to monogenic, monoallelic choice of olfactory receptor genes in mature olfactory sensory neurons needs to be further elucidated. Tex15 is transiently expressed during the critical gene regulation window in olfactory sensory neuronal progenitors, and we hypothesize that Tex15 is regulating monoallelic olfactory receptor gene choice through either methylation patterns or through its effect on chromatin state of developing olfactory sensory neurons. Through this study, I will be trained on cutting-edge molecular, cellular and computational neuroscience approaches to answer some of the broader questions of the field of olfactory sensory neuron gene expression and gene regulation patterns.